Morphology Core

The goals of the Morphology Core are to provide professional services and expertise to investigators of the Integrative Neurobiology of Cardiovascular Regulation Program Project. To facilitate these goals the Morphology Core will provide 1) technical assistance for labor intensive histotechnology techniques from tissue processing to specialized staining, 2) professional veterinary pathology support for gross, microscopic and anatomic phenotyping, 3) economic benefits througti centralization of equipment, experienced professional staff and availability of specialized histochemical/immunohistochemical reagents, and 4) consultation and instruction in specialized morphologic techniques and image analysis. Program Investigators will have full access to the Core's expertise and resources. The Morphology Core will provide its services to Program Investigators in a timely and efficient manner for optimal assessment of tissues. The Specific Aims of the Morphology Core are: 1) Provide scientific support, expertise and technical labor for microscopic slide processing from tissues, routine to specialized application of histochemical stains, and immunohistochemistry techniques. 2) Provide expertise and resources to develop new morphologic or morphometric techniques as required to facilitate the needs of Project Investigators. 3) Provide veterinary pathology support (through boarded veterinary pathologists) for examination and interpretation of gross to microscopic tissues and for consultation in experimental design. 4) Provide expertise and a uniform framework for the standardized assessment of tissues collected by Project Investigators to define a comprehensive anatomic assessment/phenotype of PPG models and experiments. RELEVANCE (See instructions): The goal of the Morphology Core is to provide professional services and expertise to Investigators of the Program Project Grant.